Understanding and Targeting the Pathophysiology of Youth-onset Type 2 Diabetes

ABSTRACT:
Type 2 diabetes (T2D) in youth reduces quality and years of life. Disparities in T2D emerge early in life and
disproportionately impact low-income and minority youth. T2D is the result of complex processes involving
biological susceptibility and interdependent social, behavioral, and environmental factors that represent the root
causes of disparities. Obesity, insulin resistance and pancreatic β-cell dysfunction have been the focus of many
clinical studies aimed at understanding the pathophysiology of T2D in youth. However, multiple factors directly
and indirectly contribute to risk including unhealthy behaviors, puberty, genetic predisposition, and epigenetic
modulation. These additional factors are influenced by the social and environmental context that must but
considered to advance our understanding of T2D in high-risk populations. Our transdisciplinary team has
extensive experience understanding, preventing, and managing T2D among vulnerable and underrepresented
youth. For over a decade, our research has been guided by a Community Advisory Board that has informed
multiple NIH-funded studies focused on T2D in vulnerable populations. Our overall approach to T2D research
is framed within an Expanded Ecodevelopmental Model that considers cultural, environmental, and social
contexts that influence individual health behaviors and health outcomes during critical life periods. We will apply
this model and leverage high-volume pediatric endocrine practice situated within one of the nation’s largest
integrated pediatric healthcare systems to recruit a diverse sample of youth with obesity and prediabetes. To
further support this work, we have developed a robust community engagement strategy to ensure that the
research extends the available science AND advances towards health equity in the local community. Our
transdisciplinary team is well-suited to contribute to a national consortium that identifies high-risk youth,
understands the pathophysiology of T2D, and ultimately improves the health of this population.
With this context, we propose the following Specific Aims:
Specific Aim 1: Enroll, phenotype, and prospectively follow an ethnically diverse cohort of 6000 (400/site)
children ages 8-14 with obesity and prediabetes.
Specific Aim 2: Integrate free living assessments of glycemia and health behaviors.
Specific Aim 3: Document family, social and environmental conditions that contribute to T2D risk.
Specific Aim 4: Collect and bank fasting blood samples to support genomic and metabolomic analyses using
validation and discovery approaches.
Specific Aim 5: Examine the individual and potential interactive effects of biological, behavioral, and social
determinants of T2D risk.

Public health relevance
NARRATIVE: Type 2 diabetes (T2D) is a complex disease that is the result of multiple factors including biology, behavior, and environment. This study will examine how various factors interact in very high risk youth to cause T2D early in life. Findings from this study will help advance the understanding of T2D in youth in order to design better prevention and treatment programs for children and adolescents.